Presynaptic Homeostatic Plasticity and Mental Health

ABSTRACT
Homeostatic plasticity (HP) encompasses a suite of compensatory physiological processes that stabilize neural
function. It is widely hypothesized that homeostatic plasticity will be linked to the cause and/or severity of
mental health disorders including autism and intellectual disability. In particular, homeostatic signaling systems
are thought to constrain the physiological outcome of genetic or environmental perturbations that confer high
risk for mental health disorders, thereby acting in a neuroprotective manner to preserve normal neuronal and
circuit function. Yet, we are only beginning to understand the intersection of homeostatic plasticity and mental
health. We recently demonstrated that the homeostatic regulation of presynaptic neurotransmitter release is
expressed in the adult developing and adult mammalian brain. This form of homeostatic regulation controls
both excitatory and inhibitory synaptic gain, thereby participating in the stabilization of excitation/inhibition
balance, a process widely considered relevant to mental health. In this grant, we present new data regarding
the molecular mechanisms of homeostatic plasticity in the mammalian brain, include genes previously
assigned as high confidence risk factors for autism and intellectual disability. Our work establishes a
mechanistic framework to associate homeostatic plasticity with the genetic underpinnings of mental health
disorders. These data open the door to future therapeutic approaches to ameliorate the severity of mental
health disorders based on the rational manipulation of homeostatic signaling.

Public health relevance
Project Narrative Homeostatic plasticity stabilizes neural function throughout life and is hypothesized to protect against genetic and environmental factors that confer high risk for mental health disorders. We will characterize novel genetic pathways, including genes previously linked to mental health disorders in human, for their role in the homeostatic maintenance of neural function in the mammalian brain, opening the door to new therapeutic strategies.